Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The Administrative Core (ADMIN) for the Center to Improve Chronic disease Outcomes through Multi-level
and Multi-generational approaches Unifying Novel Interventions and Training for health EquitY (The
COMMUNITY Center) is essential for meeting the Center’s mission. The ADMIN will fully leverage the
exceptional research and training resources and infrastructure of Columbia University Irving Medical Center
(CUIMC), Weill Cornell Medical Center (WCM) and Hunter College at the City University of New York (CUNY)
and the regional healthcare systems and networks of New York-Presbyterian (NYP) Hospital System and the
Physician Affiliate Group of New York (PAGNY) to conduct prevention, screening, treatment, and management
interventions to reduce health disparities in multiple chronic diseases. The Center focuses on rigorous testing of
interventions that incorporate the multiple levels of influence from individual, interpersonal, community and
societal approaches developed by interdisciplinary team science. We have designed three synergistic projects
that focus on novel interventions in the community and NYP health care systems employing the community
health worker (CHW) model for enrollment and/or retention into the studies while also connecting participants to
services based on five domains of Social Determinants of Health (SDoH; housing instability, food insecurity,
transportation problems, utility help needs and insurance enrollment). The ADMIN will oversee, manage, and
coordinate the range of administrative activities for the entire COMMUNITY Center (Aim 1). Within the ADMIN
we will also provide COMMUNITY Center members support for projects and pilots through Core faculty with
expertise in: 1) Biostatistics; 2) Implementation Science; 3) Data Harmonization and Biomedical Informatics. The
ADMIN will also monitor research progress and ensure implementation of the Center Plans through formal
feedback and ongoing evaluations and disseminate approaches, methods, findings and best practices across
our NYC Region and through the NIMHD Centers and health policy forums. In addition to evaluating the projects
and IDC pilots based on their deliverables, we will evaluate the other novel aspects of our program including the
CHW model and the CONNECTOME’S community projects. The COMMUNITY Center’s ultimate impact in
eliminating health disparities in multiple chronic diseases in our NYC Region will come from our collective efforts
in developing, translating and sustaining novel interventions and programs through community engaged
research that addresses synergies across prevention, treatment and management strategies. The projects that
we have developed and the pilots and community grants that will form the heart of this Center are the first steps
to meeting this goal. The ADMIN will support this mission.